The South African National HIV Pregnancy Cohort: evaluating continuity of care among women living with HIV

ABSTRACT
For the first time on a national level, we propose to utilize routinely-collected laboratory data to develop a
cohort of pregnant women living with HIV in South Africa in a way that is uniquely robust to transfer across
facilities. South Africa is home to more people living with HIV than any other country, and nearly one in three
pregnant women attending antenatal care is living with HIV. Access to antiretroviral therapy (ART) has
increased substantially since the start of the national ART program in 2004, with >95% ART coverage during
pregnancy and delivery, and mother-to-child transmission of HIV greatly reduced. However, our work has
demonstrated that women who initiate ART during pregnancy are at heightened risk of dropping out of care,
particularly after delivery, leading to the potential for viral transmission, morbidity and mortality. It is difficult to
evaluate the success of policies of expanded access to ART care, and assess continuity of care, due to the
lack of a national longitudinal HIV care database. In addition, patient movement between unlinked facilities
means that self-transfer often is misclassified as loss to care. To address this major shortcoming, our team at
the Health Economics and Epidemiology Office (HE2RO) partnered with the South African National Health
Laboratory Services in 2015 to use existing HIV-related laboratory data to create the South African National
HIV Cohort. Now, through this five-year award, we propose to expand this successful project to use routinely-
collected laboratory data to develop a cohort of pregnant women living with HIV in South Africa. We propose
three specific aims. First, we will develop and validate a novel national cohort of pregnant women accessing
HIV care. Using laboratory test data matched to facility type, we will identify entry to antenatal care to build the
cohort, then describe key treatment milestones, including 1) engagement in antenatal care, 2) initiation of ART,
3) HIV viremia, and 4) continuity of HIV care in the postpartum period. Second, we will measure the effect of
system-wide factors impacting continuity of care among pregnant women. We will assess policies of expanded
treatment access on continuity of care using regression-discontinuity analyses. We then will assess mobility
and its effect on continuity of care during and after pregnancy. Third, we will identify individual-level risk factors
for loss from HIV care in order to develop targeted interventions to improve engagement in HIV care.

Public health relevance
PROJECT NARRATIVE Women who initiate antiretroviral therapy (ART) during pregnancy in South Africa are at high risk of dropping out of care – particularly after delivery – but efforts to evaluate continuity of HIV care among pregnant and postpartum women have been hampered by lack of a national longitudinal HIV care database. Through this five-year award, we propose to use routinely-collected laboratory data to develop a national cohort of pregnant women living with HIV in South Africa that is uniquely robust to patient transfer. This novel cohort of pregnant women will be a powerful tool available to policymakers, clinicians and researchers for improving our understanding of engagement in care among pregnant women in South Africa and assessing the performance of the South African national ART program in caring for pregnant women living with HIV.